MICROANALYSIS OF RAPIDLY-FROZEN TISSUE IN THE FIELD EMISSION STEM

Measurements of elemental composition were obtained from synaptic structures in the molecular layer of mouse cerebellar cortex in order to determine physiological changes that occur after neuronal activity. X-ray microanalysis was performed on cryosections freeze-dried in the field emission STEM. Data were recorded mainly from post-synaptic endoplasmic reticulum cisterns situated in Purkinje cell dendrites and in dendritic spines, but analysis was also performed on pre-synaptic terminals, neuroglia, mitochondria, cytoplasm, and other structures.